Research Approaches to Improve the Care and Outcomes of People Living with Spina Bifida

PROJECT/SUMMARY ABSTRACT
Spina bifida (SB) is the most common permanently disabling birth defect. In the United States alone, it is
estimated that more than 150,000 individuals live with SB. Given the high medical complexity of SB care many
individuals with SB often exhibit numerous comorbidities (e.g., tethered cord syndrome, bowel/bladder
incontinence, skin ulcers, cognitive deficits, etc.). Subsequently as adults, they often have a lower health-related
quality of life, participate less in higher education, and have lower rates of employment. Much of this under-
attainment can be traced back to early neurodevelopmental deficits. However, the early risk factors contributing
to these poor neurodevelopmental outcomes are still insufficiently understood. Concurrently, with the
proliferation of prenatal myelomeningocele repair and its associated risk for premature birth, the need for
elucidating the impact of fetal repair on long-term neurodevelopmental outcomes has become more urgent than
ever. Our early studies comparing minimally invasive fetal (fetoscopic) surgery to open-hysterotomy prenatal
myelomeningocele repair, show that in addition to vaginal term births, those who were repaired fetoscopically
demonstrate comparable neurosurgical, motor, and urological outcomes to those repaired using the open-
hysterotomy approach. Furthermore, National Spina Bifida Patient Registry (NSBPR) publications have
demonstrated that some racial/ethnic health disparities may exist in this national sample. The goal of this
proposal is to investigate the outcomes related to prenatal myelomeningocele repair and concurrently investigate
if differences in the receipt of subsequent care exist based on race/ethnicity. In Aim 1, we will examine the
relationship between different approaches to fetal myelomeningocele repair and neurosurgical outcomes in order
to identify best practice standards of care. In Aim 2, we will examine the relationship between neurogenic bladder
and self-management, race/ethnicity, and fetal myelomeningocele repair in order to promote best practice
guidelines for bladder continence. Lastly in Aim 3, we will evaluate for disparities in the relationship between
race/ethnicity and the receipt of intervention for skin breakdown prevention or tethered cord syndrome in order
to identify and address any difference identified. We expect that these studies will compare the neurosurgical
and urologic outcomes of fetal MMC repair approaches in a national sample, and examine if disparities exist in
relation to the receipt of interventions and outcomes.

Public health relevance
PROJECT NARATIVE The purpose of this proposal is to work collaboratively with the Centers for Disease Control and Prevention and other spina bifida clinics to collect longitudinal data on individuals with spina bifida. The Texas Children's Hospital/Baylor College of Medicine Spina Bifida Clinic would continue to add a large and racially/ethnically diverse population, as well as a significant cohort of individuals who receive fetal myelomeningocele repair, to the national data registry. As data is collected and analyzed, changes to clinical practice may be proposed in order to develop population-level national standards for spina bifida care management and ultimately improve the lives of individuals with spina bifida.